Uncovering and harnessing connected metabolic pathways essential to virus infection.

Project Summary / Abstract
Polyamines are small, abundant molecules found in all eukaryotic cells that function in a variety of cellular
processes, including transcription and translation. These molecules are critical for cells, but RNA viruses also
require these molecules for their replication. We previously showed that RNA viruses of diverse families,
including enteroviruses, alphaviruses, and bunyaviruses, rely on polyamines to facilitate virus genome
packaging, enzyme activity, and attachment to susceptible cells. Thus, viruses usurp the cellular polyamine
resource for their own replication. However, the cell responds to infection by depleting polyamines, by acetylating
them and causing their degradation in peroxisomes. We also find that polyamines coordinate cellular metabolism
on a global levels, mediating levels of cellular nucleotides, lipids, and cholesterol, all important resources for
RNA viruses. Given the importance of polyamines for viruses, cells, and metabolism, we hypothesize that
viruses subvert cellular metabolism through polyamines to support virus replication. To test this
hypothesis, we will (1) determine how viruses use polyamines, specifically for binding to and entering susceptible
cells, (2) measure the impact of polyamines in cell stress responses – including virus infection – and their
contribution to cell survival, and (3) identify ways that polyamines interconnect with other metabolites in the
cellular metabolic network to mediate cellular homeostasis and virus infection.
We use several model systems to study polyamines and metabolites in virus infection. We use Coxsackievirus
B3 (CVB3), Rift Valley fever virus (RVFV), and chikungunya virus (CHIKV) as our primary model systems
because (1) they have robust, well-described in vitro systems, (2) my laboratory has significant experience with
these models, and (3) they represent diverse viruses such that we can compare and contrast between similar
and dissimilar phenotypes. In addition, we have model systems for poxviruses, coronaviruses, arenaviruses, and
flaviviruses that we regularly use. We showed that each of these viruses relies on polyamines, but each virus
appears to use polyamines differently, from packaging to entry to enzyme activity. Here, we will expand our
investigation, building on our significant work during the previous funding period, to determine how polyamines
function specifically during viral entry. We will also determine how cells use polyamines in the response to stress,
especially translational stress, in order to survive the stress. Finally, we will determine how polyamines connect
to other metabolites within the cell and how all of these metabolites are used to facilitate RNA virus infection,
with a particular interest in lipids. This work will illuminate the connectedness of polyamine biosynthesis to other
metabolic pathways and how viruses rely on these interconnected pathways for successful replication. This work
will highlight fundamental roles for polyamines in virus replication and in cellular metabolism.

Public health relevance
Project Narrative RNA viruses pose a constant and significant threat to human health, and our ability to combat infection is limited. Here, we propose the investigation of a class of metabolites called polyamines, to understand how they function in virus infection, in a response to stress, and in the metabolic network as a whole. This work will highlight novel host-pathogen interactions that can be exploited for the development of therapeutics.